IMMEDIATE SUPPRESSIVE VS EPISODIC THERAPY FOLLOWING NEONATAL HERPES SIMPLEX

This protocol evaluates the use of six months suppressive oral acyclovir therapy in neonates following herpes simplex virus disease limited to the skin, eye, and mouth. This is a double-blind, randomized study. Following 14 days of IV acyclovir, neonates will be randomized to receive suppressive acyclovir or to receive identically flavored placebo for a period of six months. Cutaneous HSV recurrences in either group will be treated with open label oral acyclovir.